Role of Urothelial Purinergic Signaling in Diabetic Bladder Dysfunction

PROJECT SUMMARY/ABSTRACT
Despite the high prevalence of Western diet-associated diseases and their clear impact on numerous systems
in the body, we know very little about the origin and mechanisms of bladder dysfunction in type 2 diabetes.
Current treatment strategies, although partially effective, target mainly the contractility of detrusor muscle, and
have numerous unfavorable off target side effects. We propose to study cellular and molecular mechanisms of
extracellular purinergic signaling in the bladder urothelium and suburothelium/lamina propria (LP) in bladder
dysfunctions of two mouse models of type 2 diabetes (T2D) with obesity. We will build on four important advances
made during the initial award, such as discovery of (i) mechanosensitive degradation of ATP at the luminal and
abluminal sides of the urothelium, (ii) urothelial release of soluble ectonucleotidases (s-ENTDs), (iii) differential
distribution of s-ENTDs in LP and lumen, and (iv) regulation of s-ENTDs release by various membrane channels,
sensory neuropeptides, and receptors. In pilot studies, db/db diabetic mice and mice with T2D and obesity
induced by high-fat high-sucrose diet (HFHSD-T2D) developed enlarged and underactive bladders,
accompanied by extreme ATP and ADP decrease and prominent adenosine increase in the LP but not in the
lumen. Such observations lay the foundation for the present proposal, aimed at identifying probable causes for
severe purine disbalance in the LP of the diabetic bladder that are likely linked to considerable voiding
dysfunctions. In Aim 1, we will perform comprehensive assessments of (i) voiding functions and (ii) purine
availability in LP and lumen during bladder filling in control and T2D mice. Aim 2 will determine (i) the role of s-
ENTDs in accelerated hydrolysis of ATP causing increased formation of adenosine in the LP of the diabetic
bladders, (ii) contribution of the AC-cAMP-AMPK signaling in s-ENTDs release, and (iii) distribution and cellular
sources of s-ENTDs in the bladder wall. Aim 3 will define the roles of equilibrative nucleoside transporters ENT1
and ENT2 in disproportionate accumulation of adenosine in the LP of the diabetic bladder by investigating
alterations of transmembrane and transurothelial nucleoside transport and cellular localization of ENTs. We will
use an interdisciplinary approach, including analytical chemistry, protein biochemistry, and molecular biology
techniques and genetic tools; in vivo and ex vivo evaluation of bladder function; and sonographic imaging in
nondiabetic and diabetic mice and mice with specific gene deletions. Key mechanisms of ATP hydrolysis by s-
ENTDs and regulation of their mechanosensitive release will be validated in bladders of Cynomolgus monkeys
(Macaca fascicularis) to translate findings in mice to primate biology. The proposed preclinical, discovery-
oriented research will advance our understanding of molecular mechanisms regulating availability of the
biologically active adenyl purines ATP, ADP, and adenosine at their cellular and receptor targets in the bladder
wall. This work has the potential to serve as foundational research for the development of novel therapeutics
that could influence or prevent the development of bladder dysfunctions associated with T2D and obesity.

Public health relevance
Project Narrative: Type 2 diabetes mellitus (T2D) is associated with bladder dysfunctions ranging broadly from increased urinary frequency with urgency to bladder underactivity with hesitance, that reduce remarkably quality of life. The diabetic underactive bladder is particularly difficult to manage because no effective pharmacotherapy is currently available. Therefore, there is a pressing need to identify novel treatment strategies by gaining a better understanding of the mechanisms that control bladder excitability and comprehending how these mechanisms are changed in T2D. Our studies will test the hypothesis that abnormalities of local purinergic mechanisms deep in the bladder wall are responsible for the development of diabetic bladder dysfunctions.